Genetic analysis of beneficial bacterial colonization

PARENT AWARD R35GM148385 PROJECT SUMMARY
The objective of my laboratory is to characterize how molecular communication between bacteria and their
animal hosts leads to specific and reproducible colonization. To accomplish this goal, the laboratory studies the
Vibrio fischeri-squid system, in which the animal’s “light organ” is colonized exclusively by one bacterial
species. This system is advantageous because bacteria colonize through the natural route of infection, all
animals are colonized within three hours of bacterial inoculation into the seawater, the bacteria can be subject
to detailed genetic manipulation, the precise site of infection can be imaged directly in the live animal host, and
chemical analysis of the animal host enables detailed molecular investigations. Focusing on how squid are
reproducibly colonized by the specific symbiont, to the exclusion of the millions of competing bacteria in
seawater, has revealed key roles for bacterial aggregation and biofilm formation in promoting specific host-
microbe interactions. Questions that our group is asking include: (1) How does a symbiont regulate a
beneficial biofilm? Biofilms provide microbes with a protected environment in which they can act collectively
and resist innate immune insults and antimicrobial compounds. V. fischeri elaboration of a symbiotic biofilm is
required for entry into the host, providing an opportunity to study this process in the context of a natural host
colonization model. Our past work identified BinK as a key negative regulator of biofilm formation and the
planktonic-to-biofilm transition in the host. In this study, we examine how BinK interprets signals from the host
and how that information is transmitted to V. fischeri. We examine mechanisms of signal transduction and seek
to identify and characterize a ligand that regulates BinK activity. (2) What novel bacterial factors play critical
functions in colonization processes? We have had success in applying global genetic approaches to
identify bacterial colonization factors in V. fischeri. With a focus on novel and understudied bacterial genes for
which the V. fischeri-squid system has the potential to elucidate protein functions, we identified a protein that
has a substantial impact on biofilm formation and squid colonization. The protein is annotated as a putative
RNA-binding protein, and we will characterize the molecular mechanisms by which this protein acts and
determine how it impacts symbiotic biofilm formation. (3) How do small molecules influence microbiome
specificity and colonization? We have begun to identify compounds that are present in the host and that are
co-regulated with symbiotic behaviors. We will integrate genetic approaches to elucidate signaling pathways in
the context of host colonization. A major strength of the V. fischeri-squid system is the ability to interrogate
bacterial behavior in the intact animal host, and completion of these projects will enable a deeper
understanding of the mechanisms underlying animal colonization by beneficial microbes.

Public health relevance
PARENT AWARD R35GM148385 PROJECT NARRATIVE Animal-coloning bacteria transition from an environmental lifestyle to the host-associated state, in which individual bacterial cells coordinate functions to act as a group. Using a model system that allows for interrogation of bacteria within the animal host, this project addresses how the host and microbes exchange and interpret molecular signals, leading to group versus solitary behaviors of the colonizing microbes. This project has ramifications for therapeutic interventions to establish beneficial microbes (e.g. probiotics) and to understand and interfere with colonization by pathogenic microbes.